Precision Cardiovascular Medicine for Multi-Ethnic Populations

PROJECT SUMMARY/ABSTRACT
This award will support mentored training and research needed for Dr. Arjun K. Manrai to transition to an
independent investigator position bridging biomedical informatics, cardiovascular medicine, and population
health. Throughout this award, Dr. Manrai will be mentored by Drs. Isaac S. Kohane, Joseph Loscalzo, and
John P.A. Ioannidis. The long-term goal of Dr. Manrai's research is to improve cardiovascular care and reduce
health disparities in multi-ethnic populations. A necessary step towards this goal is to clarify the impact of the
ethnicity gap between past studies and current clinical practice. Dr. Manrai's K01 proposed research builds
directly off of his previous work in translating clinical genomics across multi-ethnic populations, and includes
large-scale analyses of diverse populations (N > 45,000,000) to investigate the appropriateness of existing
genetic and clinical criteria for defining pathologic left ventricular hypertrophy (LVH) across different ethnic
groups. Dr. Manrai will use heterogeneous datasets (genomic, clinical, and insurance claims data spanning
tens of millions of individuals) to clarify the range of normal—and the appropriateness and impact of extant
criteria for defining abnormal—molecular and clinical variation in diverse populations. This work will enable Dr.
Manrai to: (1) characterize disease risks for genotype variation associated with the inherited heart disease
hypertrophic cardiomyopathy (HCM) across ancestrally diverse populations; (2) develop ethnicity-specific
phenotype reference ranges for cardiac morphology measures; and (3) measure the related healthcare
systems impact using large-scale insurance claims data.
In addition to the proposed research, Dr. Manrai will use this award to extend his background in
biomedical data science and clinical genomics with extensive, hands-on clinical cardiology training and career
development activities. Specifically, Dr. Manrai will: (1) enroll in formal echocardiography training courses and
obtain clinical cardiology exposure; (2) attend leading cardiology meetings; (3) obtain training in health
disparities and translational research; and (4) increase professional development. As part of his K01 career
development activities, Dr. Manrai will work extensively in cardiology clinics around Boston and explore
international clinical and research collaborations with clinics in Europe and Africa.
This career development award is expected to enable Dr. Manrai to transition to an independent
investigator position and lead directly to an R01 research proposal applying the research and training acquired
during the award period to study a broader set of diseases of the heart muscle (inherited cardiomyopathies
including dilated cardiomyopathy and arrhythmogenic right ventricular cardiomyopathy). Dr. Manrai's K01
proposed research is expected to yield the largest existing catalogue of multi-ethnic cardiac morphology and
genetic variation related to LVH. This information will assist physicians, researchers, and patients making
decisions with these data daily.

Public health relevance
PROJECT NARRATIVE The proposed research uses a rare confluence of large-scale genomic, clinical, and insurance claims data from tens of millions of individuals to understand how clinical criteria for heart disease impact the different ethnic groups that make up the United States. This research will help cardiologists, geneticists, researchers, and patients understand the range of healthy and unhealthy molecular and clinical variation for two widely used technologies: (1) genetic testing and (2) echocardiography. This information is a prerequisite for rational decision-making with high-dimensional molecular and clinical measurements that is needed to ensure that precision medicine serves all populations in our multi-ethnic society.